Uncovering the function of EdnrB in perivascular macrophages

Project Summary
Macrophages are ubiquitous innate immune cells that display tissue-specific function and phenotype.
Microenvironmental factors derived from a tissue niche can regulate the development of tissue specific
macrophages (TSM). The molecular basis of the specialization of TSM remains poorly understood. Perivascular
macrophages (pvMAC) are TSMs that can regulate vascular permeability and immune responses to blood-borne
pathogens. Whether and how factors unique to the vascular or perivascular microenvironment regulate pvMACs
is currently unknown. This proposal will address these key knowledge gaps. Preliminary work in our laboratory
showed that pvMACs in murine fibrosarcoma tumors promote angiogenesis and immunosuppression. We
discovered that pvMACs have high intracellular iron and express the GPCR endothelin receptor-B (EdnrB).
Macrophage-specific deletion of EdnrB led to reduced vascular density in tumors. I also found that heme induces
EdnrB expression in macrophages by inhibiting the transcription factor Bach1. Outside of tumors, I have found
that pvMACs express EdnrB in lung and adipose tissue. However, we do not know whether EdnrB expression is
a common feature of all pvMACs and whether heme regulates EdnrB expression in these cells. The expression
of EdnrB in pvMACs close to the source of the endothelin ligand (endothelial cells) and heme (circulating
erythrocytes) leads us to hypothesize that increased heme availability in the perivascular niche drives
EdnrB expression in pvMACs through degradation of Bach1 and EdnrB signaling in pvMACs regulates
vascular function. In Aim 1, I will assess the iron content and transcriptional profile of pvMACs in adipose tissue
through single cell RNA sequencing. In Aim 2, I will identify the function of EdnrB signaling in adipose tissue
pvMACs using macrophage-specific EdnrB KO mouse and reductionist ex vivo approaches. In Aim 3, I will
determine the role of Bach1 in pvMAC development and function using a Bach1 KO mouse and a model of
intravascular hemolysis. Better understanding of the biology of pvMACs is essential given the central importance
of the vascular system. This work has far-reaching implications for many pathological conditions, such as
hemolysis and ischemia. Endothelin signaling can be targeted by existing small molecule inhibitors. Hence, this
work also has the potential to be translated into appropriate clinical contexts.

Public health relevance
Project Narrative Microenvironmental factors derived from a tissue niche can regulate the development of local tissue macrophages through specialized signaling pathways. This proposal focuses on determining whether perivascular macrophage (pvMAC) endothelin signaling regulates vascular function in tissue at steady-state and whether increased heme availability in the perivascular niche drives EdnrB expression in pvMACs through the inhibition of transcriptional repressor Bach1.